Hazardous Materials Worker Health and Safety Training- HWWTP

NJ/NY Hazardous Materials Worker Training Center
HWWTP Abstract
The NJ/NY Hazardous Materials Worker Training Center has a long history of effective training that meets
the requirements of OSHA 29CFR1910.120, providing hazardous materials knowledge and skills to over
450,000 workers since 1987. Our Center will train workers about safety issues during clean-up of hazardous
waste sites, issues related to generation, treatment and storage of hazardous materials, and emergency
response. The courses develop competency in workers to critically analyze dangerous situations, and enable
them to identify safe work practices. Key principles of adult education are incorporated into our training, and
training courses are developed to include peer-learning, hands-on activities, and development critical thinking
skills. The Center has a robust evaluation plan, and will continue to expand the types of data collected on the
impact of training on workplace practice, as well as how training can more effectively influence workplace
safety culture.
The focus of the HWWT program is to provide comprehensive training for workers who clean-up hazardous
waste sites, are involved in the generation, treatment and storage of hazardous materials, and respond to
transportation and other emergencies. Over the next five years, the Center proposes to train 35,150 workers
in 1,960 courses in the HWWTP.